Imaging and Tissue Culture Core

The primary purposes of the Imaging and Cell Biology Core are to provide central facilities and technical assistance for: 1.) imaging of live and fixed cells and tissues, and 2.) isolation of fresh nerve and vascular cells for physiological study (patch clamp, calcium imaging, ROS measurements, contraction assays) and 3.) culture and manipulation of nerve and other cells. By centralizing these core techniques, Core D will enable cost efficiency because a portion of technical help and laboratory facilities/equipment will be provided, avoiding a duplication of efforts and expenditure of money by the investigators. In addition, by providing technical help, Core D provides primary investigators with a degree of quality-control and consistency in experiments as well as additional time in which investigators can follow scientific pursuits.